Adaptation of a PrEP Shared-Decision Making Tool for Family Planning Clinics

Women account for ~20% of new HIV infections in the US, and are systematically under-accessed for HIV prevention. The intersection of patient-side barriers (lack of patient knowledge, perceived risk, and medical mistrust), and provider-side barriers (lack of knowledge, discomfort with prevention counseling, and bias) impacts uptake of novel HIV prevention methods, such as available and forthcoming methods of pre-exposure prophylaxis (PrEP) for HIV (oral, injectable, etc.). To address these barriers, the trainee (Ms. Anderson) will adapt a family planning (FP) shared decision-making (SDM) tool for use in HIV prevention counseling. SDM involves introducing choice, describing options, and exploring patient preferences to aid in health care decisions, while empowering women, decreasing provider bias, increasing satisfaction with care, and increasing adherence to care regimens. The adapted tool will be tested for acceptability/feasibility with providers and clients at Title X federally-funded FP clinics, a high-reach setting for women at risk for HIV from heterosexual contact. Guided by the ADAPT-ITT framework for adaptation, the specific aims are to (1) assess the utility of SDM practices for HIV prevention and barriers/facilitators to implementation, through (a) focus groups with Title X providers in Metro Atlanta (K=4, N=32) and (b) theater testing interviews with female adult Title X clients (N=40); (2) adapt the evidence-based World Health Organization (WHO) Decision-Making Tool for FP Clients and Providers for HIV prevention; and, (3) conduct mixed-method acceptability/feasibility testing of the adapted SDM tool with Title X providers (N=40) and clients (N=40). This study will result in an acceptable and feasible HIV prevention SDM tool for use with women attending FP clinics, to be further tested and disseminated to promote HIV prevention among women, advancing efforts to end the HIV epidemic. Additionally, this work will support the training of Ms. Anderson, who is committed to becoming a high caliber, NIH-funded researcher in HIV prevention and treatment, and improvement of care interactions. Ms. Anderson’s 3-year training plan includes: (1) formally developing methodological skills in implementation science and human-centered design, (2) advancing understanding of the context of clinical HIV prevention, including biomedical prevention and clinical interactions, and (3) developing skills in the areas of measurement and evaluation of interventions and interventional pathways. The team of mentors, Drs. Sales (Primary Sponsor), Sheth (Co-Sponsor), and Kottke (Expert Advisor), will provide oversight, guidance, and mentorship to Ms. Anderson during the course of her training, in the topic areas of implementation science, HIV prevention, clinical interactions, and intervention evaluation. Ms. Anderson will leverage resources at Emory University, including the Network for Evaluation and Implementation Sciences, the Network for Evaluation and Implementation Science, the Women and Children’s Center, and the Prevention Research Center. The candidate, mentorship team, and the environment are extremely well situated to achieve the proposed research and training aims.

Public health relevance
U.S. efforts to End the HIV Epidemic have often overlooked women, who account for approximately 20% of new HIV diagnoses, and are routinely not engaged in HIV prevention services due to lack of knowledge and perceived risk- on the sides of both patient and provider- as well as insufficient integration of empowering HIV prevention counseling into routine woman-centered services, such as family planning services. Shared decision-making is a model that allows for discussion of all treatment options and empowers women to make informed health care decisions with consideration for their needs and preferences, usually through the use of a shared decision-making tool that decreases provider bias and increases provider knowledge while increasing the acceptability of care and counseling to the patient and the likelihood of adherence to the determined care plan. This adaptation of an evidence-based shared decision-making tool for use with HIV prevention in the high-reach setting of family planning clinics will provide scaffolding for improved HIV prevention counseling and increased HIV prevention method uptake, including novel and forthcoming modalities of pre-exposure prophylaxis (PrEP) for HIV prevention, advancing efforts to end the HIV epidemic among an underserviced at-risk population.